Project 2: Re-directing the Sensitivity of Metastatic Castration-Resistant Prostate Cancer to Immunotherapy

PROJECT 2: SUMMARY/ABSTRACT
Limited options are available for the treatment of mPC, a lethal prostate cancer. Immunotherapy has significantly
improved survival in patients with a variety of solid tumors; however, it has had limited efficacy in patients with
metastatic prostate cancer (mPC). There is a lack of understanding of underlying mechanisms for this de novo
resistance. In our pre-clinical studies, we have identified a novel mechanism that prostate tumors use to subvert
and evade the immune system. We have found that metastatic prostate tumor cells convert the stress-induced
immune stimulatory cell surface molecule, the MHC I Chain related molecule (MIC), to a highly immune
suppressive soluble MIC (sMIC), through proteolytic-mediated shedding. Importantly, patients with mPC have
significantly elevated immune suppressive sMIC in the circulation and severely suppressed immune cell function.
To overcome the immune suppression of sMIC, we have developed a first-in-class sMIC-targeting monoclonal
antibody (mAb) B10G5 that has demonstrated remarkable efficacy in eliminating prostate metastasis as a single
agent in preclinical models. When used in combination, B10G5 synergizes with immune checkpoint blockade
and reduces immune checkpoint therapy-induced colon toxicity. The mAb B10G5 has been optimized for human
use (termed as huB10G5), proven to be safe in non-human primates (NHP) in pilot toxicity assessments, and is
currently under IND-enabling studies. The goal of this SPORE project is to fulfill critical pre-clinical studies and
to translate the B10G5 therapy into a potential therapy for treating mPC. Very recently, we found that androgen
receptor (AR) activity could protect PC cells from immune cytotoxicity by upregulating the granzyme inhibitor
serpinB9 and that B10G5 therapy could activate FAS-mediated killing. Thus, we hypothesize that the
sMICtargeting antibody huB10G5 can be an effective immunotherapeutic agent for treating mPC as a single
agent or in combination with immune checkpoint blockade therapy and/or standard AR-targeted therapy. We
propose three Specific Aims: 1) to define the landscape of serum MIC levels in mPC patients with clinical
characteristics and association with tumor immune modulation; 2) to determine therapeutic efficacy of targeting
sMIC alone or in combination with immune checkpoint blockade (ICB) and/or AR-targeting for treatment of
concurrent visceral and bone mPC; 3) To conduct a first-in-human Phase I clinical study of huB10G5 in mCRPC
patients. These studies will provide us critical information for future Phase I expansion and Phase II study.

Public health relevance
PROJECT 2: NARRATIVE We propose to define the potential patient population with prostate cancer who would likely respond to our novel immunotherapeutic antibody. We also propose to evaluate therapeutic efficacy when combined with frontline standard therapy of mPC in preclinical models. The proposed pre-clinical study will provide rationale for optimal designing of clinical trials. As the antibody is currently under IND-enabling studies, finally, we propose to conduct Phase I clinical trial in mPC patients.